The Texas Resource Center on Minority Aging Research (RCMAR)

The purpose of the Texas RCMAR Analysis Core (AnC) is to promote and facilitate studies of aging in Hispanic
and other minority populations of Texas, the Southwestern United States, and Mexico. We focus on using
longitudinal data from survey datasets to better understand migration and aging health among older Hispanics
in the US and Mexico, in relation to social, psychological, economic, and behavioral factors. The AnC will provide
services and expertise in research design, measurement, data management, and both quantitative and
qualitative analysis to Texas RCMAR Scientists, and will serve as a resource for mentors for those conducting
pilot research. The AnC will provide monthly seminars on available data and workshops on longitudinal data
analysis and innovative analytical methods. The AnC includes biostatisticians, epidemiologists, gerontologists,
sociologists, and demographers well known in aging studies: statistical analysis of longitudinal data on Hispanic
aging (Yu), frailty, disablement, and rehabilitation (Al Snih), social determinants of health /social inequalities in
health and aging (Hill), mixed method study design and qualitative analysis (Nicklett), and aging health outcomes
research using large administrative data (Kuo). AnC specific aims are: Aim 1. Provide measurement,
statistical, and methodological support for pilot research designed to increase the number of faculty
conducting research on minority aging and health disparities. 1.a. Cooperate with the Research Education
Component (REC) to participate in the design, monitoring, data management, and statistical analysis planning
for pilot research projects. 1.b. Provide analytical mentoring to Texas RCMAR Scientists. Aim 2. Collect,
disseminate, maintain, and update infrastructure on sources of data relevant to minority aging, and
measurements of social determinants of health to all Texas RCMAR investigators. 2.a. Establish resources
on datasets for minority aging research through centralized online system and monthly seminars. 2.b. Document
and disseminate measurements of social determinants of health. 2.c. Coordinate data extraction and analytical
file generation for aging investigators and provide statistical consultation especially with respect to multilevel and
longitudinal data analysis. Aim 3. Develop, present, and disseminate instruction in advanced analytical
methods for Texas RCMAR Scientists and other RCMAR affiliates. 3.a. Develop and provide a biannual 2-
day longitudinal data analysis workshop and an annual one-day workshop on applying innovative analytical
methods on behavioral and social science research. This workshop series will cover a range of topics, including
modeling and publishing quantitative results, machine learning in social science, mixed methods, causal
inference in the social sciences. 3.b. These new training materials and resources will be disseminated through
the RCMAR Coordinating Center to the broader network of researchers in gerontology, geriatrics, and other
disciplines to foster research on Hispanic aging and health disparities. Thus, the Texas RCMAR AnC will be a
national resource supporting research in Hispanic aging and health.